Mapping the dynamics of mouse neurogenesis in autism models using high-resolution genomic barcoding technologies

PROJECT SUMMARY/ABSTRACT
The complexity of mammalian embryogenesis makes it challenging to determine the effect of genetic perturbations on
development. The long-term goal is to better understand how genetic and environmental factors alter mammalian devel-
opment to affect adult phenotypes or cause diseases. Toward achieving this long-term goal, the overall objective of this
application is to develop a platform for high-throughput retrospective lineage reconstruction to quantitatively map devel-
opmental alterations in a mouse model of autism. This platform will be based on developmental barcoding where random
mutations accumulate in synthetic loci during embryogenesis. Each mutation is inherited by the descendants of the cell in
which it occurs; each descendant can add new mutations to the ones it inherited. This process marks each cell with a set
of mutations—a barcode—that can be used to resolve its lineage. The central hypothesis is that high-resolution lineage
barcodes that are sequenced spatially in single cells can be used to retrospectively map proliferation and differentiation
dynamics of neural progenitors to identify the differences between wildtype and mutant mouse models. The rationale for
this research is that many genetic risk factors that are associated with birth defects remain mechanistically inexplicable
based on cellular and molecular analyses of terminally differentiated tissues; this platform would enable retrospective
mapping of these genetic effects after development to determine which progenitors they affect, when they affect those
progenitors, and how they affect the behavior of those progenitors during development. The central hypothesis will be
tested by pursuing three specific aims: 1) Establish high-resolution lineage recording in combinatorial and cumulative bar-
codes embedded in each cell’s genome. This Aim will combine mutagenesis from double-strand breaks, which predomi-
nantly lead to indels, with orthogonally induced point mutations to establish ultrahigh resolution lineage recording
throughout mouse gestation. 2) Establish in situ single-cell barcode and identity readout directly from mouse tissues. This
Aim will engineer barcoding loci to facilitate their amplification and sequencing in tissue sections together with molecular
markers of cell state. Combining cell state and lineage barcodes will reveal proliferation and differentiation dynamics of
their progenitors. 3) Determine the effects of Chd8 haploinsufficiency on the development of mouse brain using retro-
spective lineage reconstruction. Chd8 haploinsufficiency causes autism but how it alters neurogenesis remains unclear.
This aim will quantify the effects of Chd8 haploinsufficiency on proliferation and differentiation parameters of brain pro-
genitors during mouse neurogenesis. The research proposed here is innovative because it establishes new strategies for
high-resolution genomic barcoding of lineages and high-throughput spatial sequencing of these barcodes in tissue sec-
tions. It further uses new theoretical concepts to convert terminal cells’ lineage barcodes and molecular identity infor-
mation to quantitative insights about their progenitors. Additionally, it carries out in utero analysis of how Chd8 haploin-
sufficiency alters progenitor fields that create the brain. This research is significant because it will enable determining how
genetic perturbations alter mammalian embryogenesis to cause developmental anomalies such as autism.

Public health relevance
PROJECT NARRATIVE Developmental anomalies affect more than 120,000 births annually in the United States; however, the perturbations in embryogenesis that lead to these anomalies have not been identified in many cases including certain neurodevelopmental disorders. The proposed research creates strategies for detailed mapping of developmental events in mammalian model systems to advance the understanding of the genetic factors that contribute to these disorders. These strategies are relevant to public health and the NIH’s mission because they would help determine how genomic mutations disrupt cell proliferation and differentiation during embryogenesis to lead to developmental anomalies.